SCLC Model Generation and Therapeutic Analysis

Project Summary
The laboratory mouse plays a central role in the preclinical development of new therapeutic strategies
and through the application of transgenic technology has proven to represent a clean genetic model to test
hypotheses related to the molecular of cancer etiology. Moreover, these models are generally reliable
predictors of drug pharmacokinetics, pharmacodynamics, and efficacy in vivo.
Core B proposes two Specific Aims. Specific Aim 1 will engineer human and mouse cell lines using
CRISPR genome engineering to disrupt genes identified by each of the Projects, confirm loss of function
through robust quality control, and distribute these cell lines to the Projects for further analysis. Somatic
genome engineering will be used to generate GEMM models that have specific genes co-mutated ab initio to
test their role in treatment response, Specific Aim 2 will provide professionalized in vivo therapeutic analysis
using the models already in hand or generated in the previous aim, standardizing treatment studies between
each of the Projects.
These Specific Aims will bring to bear multiple cutting-edge technologies used for in vivo cancer
modeling, disease monitoring by small animal imaging, pharmacodynamic analysis, and combination efficacy
studies to directly test the hypotheses generated in each of the Projects.

Public health relevance
PROJECT NARRATIVE High-fidelity cancer models that accurately reflect human small cell lung cancer biology play a key role in the development of new therapeutic strategies. The Model Generation and Therapeutic Analysis Core (Core B) for this Program will use CRISPR genome engineering technology to generate isogenic SCLC cell lines and somatically engineered mouse models, and streamline in vivo therapeutic analysis.